Enhancing Parent-Child Communication to Reduce Media Influence on Substance Use

Abstract
The rates of adolescent substance use in the U.S. indicate the need for evidence-based prevention programs
that include a discussion of alcohol, tobacco, electronic vapor products, marijuana, and opioids. Parents can
significantly impact their children’s substance use beliefs and behaviors and are vital to prevention.
Unfortunately, many parents feel that they have little influence on whether or not their child uses drugs. While
high-quality parent-child communication about substances is a protective factor, parents often find it
challenging to effectively engage in these conversations with their children. Youth consume a plethora of media
messages that promote and glamorize drugs (e.g., advertising, social media, popular music, television shows),
and exposure to these media messages predicts youth substance use. Media literacy education (MLE), which
includes the critical analyses of media messages, is an effective approach to youth substance use prevention,
including family-based youth prevention programming. The first aim of this project is to create Media World
Parent (MWP), a self-paced program designed to provide parents of middle school-aged students with
knowledge about teen substance use, media mediation skills, and practice in high quality parent-adolescent
communication methods delivered through a highly interactive web-based software application. It is
hypothesized that this program will enhance parents’ feelings of efficacy for and participation in open,
responsive, comprehensive, and accurate parent-child communication about substance use, including critically
analysis of media messages that promote substance use. In turn, we hypothesize that these parent-child
conversations will positively impact children’s media literacy skills and outcomes related to substance use (e.g.,
beliefs, intentions, behavior). The proposed program will utilize a media literacy framework (e.g., Message
Interpretation Process model) found to be effective in reducing risk behaviors, including substance use. This
project is innovative because the program expands upon a successful theoretical prevention framework, uses
MLE to address the typically unaddressed influence of media on youth substance use, covers multiple
substances including electronic vapor products and opioids, and uses highly interactive web-based
functionality with mobile boosters. The program will be iteratively developed and refined with input from a
diverse Advisory Panel of parents, youth, and prevention specialists. The second aim is to conduct a feasibility
study of the MWP program in which a diverse sample of parent-child pairs (N=286) are randomly assigned to
an intervention group (MWP) or an active control group (e.g., medically-accurate web content on adolescent
substance use). Parents and youth will complete pre-post assessments, which will provide a preliminary test of
program effectiveness for positively affecting outcomes. Program feedback ratings will also be used to evaluate
program feasibility. If feasibility is determined, findings will be used to inform program revisions and the
design of a larger-scale RCT to examine the program’s impact on adolescent outcomes over time.

Public health relevance
Project Narrative High-quality parent-child communication and parental media mediation are established protective factors against adolescent substance use. The purpose of this project is to develop and test the feasibility of a self- paced online program designed to provide parents with media literacy and media mediation skills, knowledge about adolescent substance use, and practice in high quality parent-child communication methods delivered through an interactive and customizable web-based software application. The proposed research has the potential to move the field forward because it would fill a gap in existing resources for parents and addresses the often ignored influence of media on adolescent substance use while bolstering the protective impact of high-quality parent-child communication.